Learning Health systems training to improve Disability and chronic condition care (LeaHD) Research Education Core

ABSTRACT: RESEARCH EDUCATION CORE
The Research Education Core (REC) will facilitate skills development and mentored training experiences for
scientists embedded with one of our nine LHS Innovation Hub health system partners. The REC will be
responsible for preliminary application review for LeaHD scientist positions, conducting candidate interviews,
and administering the LHS Research Core Competency Needs Assessment. The REC will rate applications
and make final selection and recommendations for LeaHD scientist appointments. The REC will match
scientists with academic mentors, health systems partners, and on-site mentors for experiential training. The
REC will use LHS research competency results to identify training gaps and goals, and to suggest training
activities. The REC will oversee development of individualized training plans (IDPs) that clearly define goals,
training activities, and deliverables, and mentoring agreements which define the parameters for the academic
mentor-mentee relationship. It will review IDPs and mentoring plans at the outset of the program and
biannually thereafter. The LeaHD training program will implement a structured training plan with required
elements (e.g., PCORI Methodology Standards curriculum), individualized components, health system
engagement, and evaluation. Over the course of five years, the REC will train 13 embedded scientists (12
supported by AHRQ, one by Brown University). The REC will provide structured and individualized didactic
training opportunities, dedicated professional development funds, travel support, information resources, and
technical support. The scientist stipend will support ~40% time and effort for a junior faculty member or full-
time effort for a postdoctoral fellow for 18 months. Additional funding will be provided to cover research
expenses or extended training as needed. Eligible applicants must have doctoral level or equivalent training
and prior research experience focused on rehabilitation or long term services and support for persons with
disability and/or chronic conditions. Finally, the REC will identify and collaborate with health system partners to
secure additional funding to support and sustain LHS research efforts.
IMPACT: The REC will ensure that LeaHD’s embedded scientist program provides mentored training and
health system engagement to foster long-term, successful careers in LHS research for scientists whose work
focuses on improving care for persons with disability and chronic conditions.